Dentin-pulp dynamics of aging teeth

PROJECT SUMMARY/ABSTRACT
The introduction of new strategies harnessing the regenerative capacity of the dentin-pulp complex may make
it possible for humans to retain their natural teeth throughout their lifespan. Research has demonstrated that
dental pulp stem cells maintain extraordinary characteristics that can provide clinical options for dental care
and restoration. However, it remains unknown whether older patients are also able to benefit from these tech-
nologies. The long-term goal of this project is to gain an understanding of how teeth change throughout adult-
hood in order to develop treatments that can preserve or enhance tooth health and permit retention throughout
the lifespan. Our objective is to analyze the dentin-pulp interface in young and old rodent molars to qualitatively
determine how the regenerative capacity of the dentin-pulp complex changes with age. Our central hypothesis
is that age-related changes to the DP mesenchyme, vasculature, and innervation alter the secretion and avail-
ability of bioactive proteins in dentin (BPiD) and that pulpal senescence, in combination with reduced access to
BPiD, reduces tooth vitality with age. The rationale for this project is that a detailed scientific framework of
tooth aging and regeneration is likely to uncover molecular candidates for vital pulp therapies. The central hy-
pothesis will be tested with the following specific aims: 1) Identify secreted bioactive proteins in dentin that
change with age; and 2) Analyze age-dependent changes in teeth. Under the first aim, molars from young and
old rats will be extracted, divided into root and crown portions, and milled for subsequent proteomic analyses of
the dentin composition. ELISA and/or immunofluorescence will verify location and abundance in order to iden-
tify secreted proteins of interest that could regulate neurovascular responses during injury and/or regeneration.
For the second aim, mouse molar dentin in 3- and 20-month mice will be surgically damaged and analyzed at
varying time points to assess: a) elasticity and hardness using nanoindentation assays; b) mineralized volume
and density determined by microcomputed tomography (micro-CT); and c) dental pulp neurovascular injury
responses based on confocal imaging. The research proposed in this application is innovative because it pro-
vides a comprehensive view of how teeth age using several techniques applied to preclinical murine models
from young and elderly stages. The proposed research is significant because it is expected to identify vital pulp
therapy and regenerative endodontics candidates for continued research and future clinical trials with patients
in different stages of life. Ultimately, such knowledge has the potential to offer new dental treatments to help
patients maintain their dental health and retain their natural teeth into old age.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it aims to improve tooth health and retention into old age, thereby improving overall quality of life for an increasingly larger segment of the world population. This research stands to reveal candidates to test in follow-up tooth regeneration experiments that could help de- velop new pulp therapies and greatly improve dental healthcare at all stages of life. Thus, the proposed re- search is relevant to the NIDCR’s mission to improve dental healthcare through research and dissemination of health information.